LINKAGE HONEST BROKER (LHB) SERVICES FOR THE NATIONAL CLINICAL COHORT COLLABORATIVE (N3C)

N3C is a national resource of real-world data that researchers are using to speed medical research.

With stewardship from NCATS, more than 90 institutions worked together to build N3C. N3C systematically collects electronic health record (EHR) data from different institutions and harmonizes them into a central enclave. The enclave offers spaces for collaborative research. In addition, EHR data within the enclave can connect to other data sets, which creates a more complete picture of patients’ health journeys.

NCATS is leveraging the original N3C infrastructure in new ways to expand into new disease domains and cover Real-World Data training needs for researchers.

We know that the data in the enclave represents people. As the steward of the data, we take seriously the responsibility of keeping those data safe. Our comprehensive approach addresses the security of the N3C Enclave and protects patient privacy.